Tech-Train-Dissem Core

TRAINING AND DISSEMINATION: PROJECT SUMMARY
The field of Immunoengineering is a rapidly growing combination of two diverse, complex fields: engineering and
immunology. In each, there is a widespread lack of fundamental understanding of the other. JH-TIE will continue
to take a leadership position in breaking down barriers between the fields by providing broad dissemination of
immunoengineering principles, tools, and technical advances and facilitating collaborations between
immunologists and engineers. The P41 mechanism is an ideal opportunity to overcome the divide between
researchers in immunology and engineering.
JH-TIE will make the lexicon, approach, and tools of immunoengineering accessible to a wide array of
researchers; our vision is to become a hub and thought leader for immunoengineering. Our researchers will
disseminate our work through scholarly publications, workshops, conference posters and presentations, and our
dedicated JH-TIE websitei for use by collaborative participants worldwide. JH-TIE will continue to host our
Translational Immunoengineering Workshop and Course every January and extend our educational
programming through the year via our new Translational Immunoengineering Seminar Series. Also, new in this
grant cycle, we will be running an innovative combined educational and hackathon initiative through JH-TIE
(“Frameshift”) that will offer opportunities for in-person dissemination of JH-TIE technologies and serve to
nucleate new Collaborative and Service Projects.
With an integrated immunology-and-engineering approach, we can address a myriad of challenges in a wide
variety of applications such as cancer immunotherapy and tissue engineering. Blurring the lines between
immunology and engineering offers the opportunity for unique synergy in medicine. Our education, training, and
dissemination goals will help ensure the impacts of JH-TIE extend well beyond our immediate research goals
and persist as our message and trainees propagate.